Summer Endocrine Research Training Program

Abstract:
This is a competing renewal application for a T35 short term medical student summer training program in
endocrine research that has been funded by NIDDK for 15 years. The 2 Specific Aims are 1) To provide
hands-on training in basic and clinical Endocrine-related research to medical students in a structured mentored
environment; 2) To provide an interactive, educational experience that introduces medical students the
fundamental skills necessary for basic, translational, and clinical Endocrine-related research. The program has
supported the training of 6 second year medical students in endocrine research topics including diabetes – with
a particular focus on diabetic kidney disease, endocrine malignancies, pituitary regulation of peptide hormone
expression, non-alcoholic fatty liver disease, cardiovascular complications of diabetes and obesity, hormonal
regulation of metabolism, and stem cell biology. Trainees are selected from the first year class at University of
Louisville School of Medicine (SOM) applying for the summer research scholar program (SRSP). A successful
effort has been made to recruit students from underrepresented minorities and disadvantaged backgrounds.
Students review the available projects submitted by 28 faculty research mentors and enter their 1st-3rd choices,
allowing matching of trainees with mentors. In-person meetings between trainees and mentors assures the ‘fit’
in the middle of the Spring semester. During the 10 week summer training, students work with mentors on
research projects in clinical or laboratory settings, complete training in the Responsible Conduct of Research,
including managing scientific data, fabrication and falsification of data, plagiarism, publication practices and
responsible authorship, mentorship, stewardship, and conflict of interest. Trainees working with human
subjects complete human subject and IRB training. Trainees who use vertebrate animals in mentors’ labs
complete and pass IACUC training courses. All trainees attend a weekly Summer Endocrine Research
Training Class to introduce clinical/translational research in endocrinology. An essential component well-
integrated into this class by T35 faculty mentors is discussion of methods for enhancing reproducibility. The
Class culminates with each trainee presenting his/her research project to peers and mentors. Trainees also
present their research results as posters at a SOM-wide, week-long celebration of Research!Louisville.
Winners from the poster contest have the opportunity to attend the National Student Research Forum the
following Spring. Trainees may choose to continue research as part of the Distinction in Research (DIR) track
enrichment program that provides research experiences throughout the medical school curriculum, including in
the third and fourth years, toward the goal of developing clinician-researchers. Student trainees have published
in peer reviewed journals and/or presented their research in national or international forums and many have
received the DIR notation on their medical school diplomas. Trainee career outcomes are tracked to assess
the impact of this T35 program on careers as physician-scientists.

Public health relevance
Understanding the aberrant hormonal and genetic regulation of cellular homeostasis is the key to unraveling chronic and emerging disease and to develop new treatment strategies. The major goal of this project is to provide medical students who have completed at least one year of medical school with a hands-on summer research experience in NIDDK-focused research on endocrine-related health concerns to stimulate their interest in a clinical-research career.